DP21-001 PRAMS DISTRICT OF COLUMBIA

Abstract
PRAMS is a surveillance project of the Centers for Disease Control and Prevention (CDC) and
state health departments. DC PRAMS is a population-based surveillance on selected maternal
behaviors and experiences that occur prior to, during, and shortly after pregnancy, including
emerging issues (e.g., COVID-19), among women with a recent birth. Mothers are selected at
random from DC birth registration system. Expected outcomes are: 1) Timely, high quality data
source that is representative of mothers who recently gave birth in DC that can be used to
monitor prevalence of maternal behaviors and experiences to inform programs, research and
system changes that influence maternal and infant health. 2) Data will be available to CDC and
DC Health, and other partners for studies of surrounding maternal behaviors and experiences
before, during, and shortly after pregnancy. 3) DC Health and CDC will use the PRAMS
methodology to obtain data to inform the rapidly emerging issues related to maternal and child
health that arise during the data collection cycle, including post-disaster or emergency
surveillance, for example, COVID-19.

Public health relevance
PRAMS is a population-based surveillance project of the CDC and state health departments. PRAMS collects state-specific data for the District of Columbia on maternal attitudes and experiences before, during and shortly after pregnancy.